Spatial-Temporal Organization and Function of Spinal Locomotor Networks

DESCRIPTION (provided by applicant): Experiments described in this proposal will investigate the cellular constituents and arrangement of motor pattern generating circuits in the spinal cord. Recently, general organizing principles have been established for spinal circuitry. However, further dissection of these circuits is hampered by a lack of markers for precise functional classes of neurons, and technological obstacles in recording the activity of large numbers of neurons. Proposed experiments will test the hypothesis that evolutionarily conserved elements in transcription factor promoters are sufficient drive gene expression in functionally defined neuronal populations. A combination of genetic and optical approaches will allow the identification of novel neuron types and their functional characterization in an intact, functioning neural network. Overall, these experiments will provide a detailed spatial-temporal picture of how spinal systems coordinate movements. PUBLIC HEALTH RELEVANCE: Neural networks in the spinal cord are capable of generating coordinated movements without instructions from the brain. In most instances of spinal cord injury, much of the spinal cord remains intact, and theoretically able to generate movements. With an understanding of spinal circuits at the cellular level, therapies may be effectively targeted within the spinal cord, facilitating recovery of motor function after injury.)

Public health relevance
Relevance: Neural networks in the spinal cord are capable of generating coordinated movements without "instructions" from the brain. In most instances of spinal cord injury, much of the spinal cord remains intact, and theoretically able to generate movements. With an understanding of spinal circuits at the cellular level, therapies may be effectively targeted within the spinal cord, facilitating recovery of motor function after injury.)